A Novel Modular Polymer Platform for the Treatment of Oral SCCA

DESCRIPTION (provided by applicant): Maie St. John, MD, PhD is an Assistant Professor of Surgery at UCLA with a clinical focus in oral and oropharyngeal cancer. Her career goals are: 1) Research - To develop a scientific portfolio in translational applications of the understanding of mechanisms of tumor progression and metastasis in oral cancer: incorporating the results of her laboratory-based research into the development of novel therapies for OSCC; and to mature into an independent scientist who can successfully compete for funding. 2) Clinical - To become an academic leader in oral & oropharyngeal cancer surgery known for patient oriented research. In order to achieve these goals, she will receive mentorship from Steven M. Dubinett, M.D. and Cun-Yu Wang, DDS, PhD, and the mentoring committee comprised of senior faculty members. She will be in a highly protected, stimulating research environment devoted to translational research in oral cancer. She is enrolled in the UCLA K30 Graduate Training Program in Translational Investigation to receive a degree in Clinical Research with an individualized didactic curriculum in translational and patient oriented research. Her research project entails the development of a novel biocompatible modular polymer platform which will improve the outcome for patients with advanced or recurrent Oral and Oropharyngeal Squamous Cell Carcinomas (OSCC). The management of these patients poses a considerable challenge to the surgeon and the radiation oncologist. The surgical demand in such a setting is for wider resection or, in some instances when the tumor is fixed to the underlying vital structures, to debulk as much of a large tumor as possible and leave behind the unresectable portions. Unfortunately, local failure in these cases is at least 40% or greater. The ability to decrease mortality, and improve quality of life and survival for these patients has been a longstanding goal. Dr. St. John has developed a polymer wrap that has the following characteristics: is biocompatible; is slowly degradable; and can serve as a platform to deliver immunomodulators and chemotherapeutic agents so as to most effectively kill tumor cells in the proximity of the polymer application. This polymer wrap is designed to be applied intraoperatively to the surgical bed after removing or debulking the tumor, thus allowing for enhanced post-operative radiation treatment, and also functioning as a platform for the delivery of immunomodulators. Besides its clinically relevant features, the modular nature of this polymer platform provides an elegant approach to future investigations, allowing the identification of specific molecular targets. The ultimate validation will be in the context of a prospective trial in patients with unresectable advanced or recurrent OSCC.

Public health relevance
PUBLIC HEALTH RELEVANCE: OSCC is the sixth most common cancer in the world, and patients with OSCC are at considerable risk of mortality, with more than 300,000 deaths attributable to the disease annually. During the past 30 years, the 3- to 5-year survival rate of patients with advanced OSCC has remained poor (20-30%). This modular polymer platform is a novel treatment strategy that addresses the need for new therapies in this disease. Relevance to Public Health OSCC is the sixth most common cancer in the world, and patients with OSCC are at considerable risk of mortality, with more than 300,000 deaths attributable to the disease annually. During the past 30 years, the 3- to 5-year survival rate of patients with advanced OSCC has remained poor (20-30%). This modular polymer platform is a novel treatment strategy that addresses the need for new therapies in this disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS This project focuses on the development of a novel biocompatible modular polymer platform which will improve the outcome for patients with advanced or recurrent Oral and Oropharyngeal Squamous Cell Carcinoma (OSCC). The management of these OSCC patients poses a considerable challenge to the surgeon and the radiation oncologist. The surgical demand in such a setting is for wider resection or, in some instances when the tumor is fixed to the underlying vital structures, to debulk large tumors. Unfortunately, local failure in these cases is at least 40% or greater. The ability to decrease mortality, and improve survival for these patients has been a longstanding goal for cancer researchers. We have developed a polymer sheet that has the following characteristics: is biocompatible; is ultimately biodegradable into biocompatible breakdown products; and can serve as a platform to deliver immunomodulators and chemotherapeutic agents so as to most effectively kill tumor cells in the proximity of the polymer application. This polymer wrap is designed to be applied intraoperatively to the surgical bed after removing or debulking the tumor, thus allowing for enhanced post-operative radiation treatment, and also functioning as a platform for the delivery of immunomodulators. Pilot studies show that the prototype polymer sheet can significantly reduce in vivo tumor size even in the absence of radiation . In this study, the polymer will be evaluated in the presence of radiation and the polymer's interaction with ionizing radiation will be determined. As the recurrence rates in patients with advanced OSCC are high, by enhancing the anti-tumoral effect of radiation may reduce recurrence as well. We hypothesize that 1) the local delivery of chemotherapeutic agents will enhance tumor reduction, 2) the local delivery of immunomodulators will increase the efficiency of tumor cell killing by the host's immune system, and 3) the modular nature of our polymer platform will allow us to customize it for individual patient tumors. The modular nature of this polymer platform also provides an elegant approach to future investigations, allowing us to seek out specific molecular targets. This will enable us to dissect underlying mechanisms of immune activation and expansion, which will in turn help us design additional strategies to block the inactivation and death of the cytotoxic effectors in patients with aggressive OSCC. Our ultimate goal is to be able to customize the polymer for individual patient tumors. Three Specific Aims are in place to accomplish these goals. The methodologies used for this evaluation will prove useful for guiding future therapeutic platforms for this challenging disease. Specific Aim 1: Determine the efficacy of the polymer as a platform for chemotherapeutic delivery in combination with Radiation Therapy (Year 1). Specific Aim 1a. Determine the release kinetics of cisplatin under the influence of ionizing radiation. Specific Aim 1b. Assess the in vivo efficacy of the Chemotherapeutic Layer of the polymer, in combination with radiation treatment. Specific Aim 2: Determine the efficacy of the polymer as a platform for immunomodulator delivery in the presence of Radiation Therapy (Year 2). Specific Aim 2a. Determine the release kinetics of the immunomodulators (IL-7 and CCL21) under the influence of ionizing radiation. Specific Aim 2b. Assess the in vivo efficacy of the bilayer polymer (Chemotherapeutic and Immunomodulator layers), in combination with radiation treatment. Specific Aim 3: Customize the Polymer for Individual Patient Tumors (Year 3-5). We will use the DCTD (Division of Cancer Treatment and Diagnosis) approved oncology drugs to screen against a panel of established and primary (obtained from our patients) human oral cancer cell lines. Several candidates identified in the screen will be further tested in our polymer platform in vivo in the SCID/Beige model. Tumor burden will be quantified and correlated with markers of tumor cell proliferation (Ki67) and apoptosis marker (Annnexin V). We will also quantify stem cell markers before and after treatment in vitro and in vivo by cell surface staining with fluorescent labeled antibodies and detected by flow cytometry. Markers will include at least one embryonic stem cell marker on the surface of the stem cells, wherein the embryonic stem cell marker is Oct 3/4 or Nanog; and, at least one stem cell marker comprising, activated Stat-3 CXCR4, CD 133, SCA-1, Tra-1-60, CD 44, CD 73, CD 90, CD 105 and Stro-1. The results obtained from these Specific Aims are expected to validate our hypotheses, and produce the critical data toward a prospective trial in patients with unresectable advanced or recurrent OSCC. Towards the completion of this K23 Award, I plan to be in position to launch a Clinical Trial using this novel modular polymer platform in patients with advanced Oral cancers, and successfully compete for funding (RO1).